CTSA Postdoctoral T32 at the University of Alabama at Birmingham

Project Summary/Abstract
Dissemination and implementation (D&I) science is the study of how to effectively translate research findings
into practice and policy. By integrating dissemination and implementation science into the clinical and
translational science spectrum, researchers and practitioners can better understand the factors that influence
the uptake of evidence-based practices and develop strategies to overcome barriers to implementation.
However, in the Deep South, there is a critical shortage of professionals broadly . This limits the ability of
researchers and practitioners to develop and implement effective interventions to address health disparities
and improve health equity. Hence the objective of this proposed program is to launch the first T32 postdoctoral
training program dedicated to the integration of dissemination and implementation science within and across
the translational science spectrum. We seek applications from MDs, PhDs, and doctoral candidates, from a
wide range of clinical and scientific disciplines, and diverse personal backgrounds. The proposed program will
take full advantage of the stellar resources of the Clinical and Translational Science Center at the University of
Alabama at Birmingham and related Deep South Partner Network. The program’s aims are to: [1] Identify,
recruit, and train a diverse cadre of postdoctoral scientists with the knowledge, skills, and experience
to become independent investigators who will continue to expand the field of dissemination and
implementation; [2] Establish a rigorous, innovative training program in dissemination and
implementation science to facilitate nuanced integration of D&I domains within and across the
translational science spectrum; [3] Enhance the integration of D&I and clinical and translational
science by embracing health equity as a critical, key focus area of scientific advancement. This
proposal has 4 distinguishing characteristics: (1) Integration with an NCATS-supported Clinical and
Translational Science Hub at UAB and Partner Network comprised of 11 institutions across the Deep South of
the US; (2) D&I mentors and resources representing an extraordinary breadth of disciplines across the
translational spectrum; (3) A focus on D&I research centered in addressing health inequities in the Deep
South, and (4) An training design anchored in diversity, equity, inclusion, and accessibility. Didactic
components leverage coursework developed by UAB and Partner Network investigators, and additional UAB
programs that have trained generations of scientists in clinical investigation, translational science, and public
health research methods. Training duration will be 2 years. We will have 5 slots per year. Successful
candidates must show evidence of a strong commitment to D&I science a commitment to health equity
research. Trainee progress will be monitored and evaluated by the Program Directors, mentors, and advisory
committees.

Public health relevance
Project Narrative Dissemination and implementation (D&I) science is the study of how to effectively and efficiently spread evidence-based practices and interventions to the people who can benefit from them. It is important to integrate this type of science into the clinical and translational science spectrum because it helps ensure that new treatments and therapies are not just developed, but also effectively implemented and used in real-world settings. This can ultimately lead to improved health outcomes for individuals and communities. This postdoctoral training program will train new scientists in D&I science so we can take better care of people and improve inequities in health and health outcomes.